2013 LAM Symposium

DESCRIPTION (provided by applicant): The LAM Foundation 2013 Lymphangioleiomyomatosis International Research Conference will focus on the molecular mechanisms of smooth muscle proliferation and cystic lung destruction that occur in the fatal lung disease of women, Lymphangioleiomyomatosis (LAM). This is the fourteenth annual Cincinnati LAM conference, which has evolved from a dedicated family/patient conference to a state of the art scientific meeting for LAM and tuberous sclerosis. The basic science sessions will highlight research on the cellular and genetic basis of smooth muscle proliferation in LAM, and will focus on the role of exogenous growth factors, sex hormones, genetic mutations, lymphangiogenesis, intracellular signaling mechanisms and changes in transcriptional regulation in disease pathogenesis. Additional sessions will explore the link between smooth muscle infiltration of the lungs and the cystic remodeling of pulmonary parenchyma, including the elaboration of metalloproteinases and connective tissue matrix by LAM cells. More clinically oriented talks will be incorporated into most sessions, to address difficult management issues in LAM, including hormonal therapy, air travel, pregnancy, lung transplantation and pleural complications. A concurrent patient-oriented seminar series will address key clinical issues for 175 LAM patients and LAM family members who are expected to attend, and will culminate in a summary of scientific sessions by the Basic and Clinical Track Chairs. A scientific roundtable discussion is held on the last day of the conference to review the key outcomes of the conference and to plan future conferences. Each session will be chaired by an expert in the field and will have invited speakers as well as speakers chosen from the pool of submitted abstracts. There has been a conscious effort to attract established investigators from related disciplines who can complement the expertise of the current pool of LAM investigators. Discussion facilitated by a discussion leader will be an important component of all sessions. Outstanding junior investigators will be awarded travel grants based on merit and will be given the opportunity to present their research in platform and poster formats. The goal of this conference is to provide a forum for leading experts to discuss the molecular and cellular basis of LAM, review the clinical management of LAM, to present cutting edge research, to integrate concepts and to identify creative and innovative research directions.

Public health relevance
The 2013 LAM Research conference is the fourteenth in a long history of collaborative NIH/LAM Foundation conferences. Each year, this multidisciplinary conference draws experts in interstitial lung disease, smooth muscle biology, mTOR signaling, lymphangiogenesis, pathology, radiology and endocrinology. The participation of patients as integral contributors, including roles as speakers, teachers, learners, and fund raisers, is perhaps the most innovative and motivating aspect of this unique meeting.